Microfluidic Systems to Enable Enzyme Engineering for Chemical Synthesis

PROJECT SUMMARY
The overall objective of this work is to develop and apply a droplet microfluidic system to facilitate rapid
engineering of enzymes to synthesize drug molecules. Development of new medicines requires synthesis of
complex molecules from initial lead compounds for testing. Once a drug is identified, efficient synthesis is
needed for clinical trials and ultimately widespread production. Traditionally such syntheses utilize metal-based
catalysts. Enzyme and cell-based systems offer numerous potential advantages including greater selectivity in
installing functional groups, greener reactions, more efficient catalysts, and low toxicity. Creating biocatalysts
with the desired selectivity requires enzyme engineering. The potential of enzyme engineering is seen in the
awarding of a Nobel Prize in 2018 and uptake by pharmaceutical manufacturers. Enzyme engineering requires
creation and isolation of thousands of enzyme variants, incubation of substrates with variants, screening of the
variants for reaction activity, and identification of variants for further mutation and evolution. Current methods
for engineering that use robotics, well plates, and liquid chromatography-mass spectrometry are time and
resource intensive thus limiting the use in medicinal chemistry. Droplet microfluidics has potential to profoundly
improve enzyme engineering through greater speed and substantially reduced materials requirements. In
these methods, individual enzyme variants are encapsulated into droplets, screened for product formation, and
sorted based on signal. The low volumes required (< 10 nL/reaction) and high-throughput (over 1000
samples/s) are dramatic improvements over current well-plate methods. However, early demonstrations of
enzyme engineering by droplet microfluidics are impractical for development of biocatalysts due to a reliance
on fluorescence detection in screening. We propose to create droplet microfluidic enzyme engineering systems
that utilize mass spectrometry (MS)-based detection, offering the potential for label-free and information-rich
screens at high throughput. In preliminary work, we have developed “mass-activated droplet sorting” (MADS)
which can sort enzymes expressed in vitro based on their activity detected by MS. We will build on this
achievement to create a versatile system with advanced analytical measurements for enzyme engineering.
Many enzyme engineering protocols call for expressing the variants in microbes, therefore we will
develop tools to allow individual microbe strains to be grown in single droplets and sorted by MS. Prior work
has relied on direct analysis of droplets by MS; however, this precludes separations of isomers and can be
vulnerable to matrix effects on signal. We will expand analytical options by interfacing droplets to rapid LC-MS
and ion mobility-MS to offer separations of isomers and matrix before MS detection. The system will be used to
engineer pyridoxal phosphate-dependent enzymes for the diversification of amino acid substrates and
cytochrome P450s that mediate intermolecular oxidative C–H/C–H coupling reactions to form C–C bonds.

Public health relevance
PROJECT NARRATIVE Development of medicines requires technology for rapid and efficient synthesis of new molecules. This project will develop of a novel platform for high-throughput reaction development and discovery based on engineering enzymes using nanoliter droplet technology and high-throughput analytical systems compatible with organic reactions. By providing access to enhanced throughput and miniaturization, this technology will accelerate pharmaceutical discovery and development in a time and resource efficient manner.